Columbia Population Research Center

Abstract – Overall Component
This application seeks P2C continuation funding for the Columbia Population Research Center (CPRC), co-
directed by Jennifer S. Hirsch, Professor of Sociomedical Sciences at the Mailman School of Public Health, and
Jane Waldfogel, Compton Foundation Centennial Professor for the Prevention of Children's and Youth
Problems at the Columbia University School of Social Work. CPRC's mission is to increase the scientific impact,
innovation, and productivity of population researchers at Columbia, increase their competitiveness for peer-
reviewed external funding in population dynamics research, help junior population scientists achieve research
independence, and maximize the efficiency of funding for population dynamics research. To achieve that
mission, our specific aims are to: (1) nourish a vibrant cross-campus intellectual community of population
researchers at Columbia, fostering the development of junior population scientists and encouraging
collaborations among population scientists and between population scientists and scientists in other
disciplines; (2) advance population research in CPRC's four primary research areas (PRAs): children, youth,
and families; reproductive health and HIV; immigration/migration; and urbanism; (3) continue to be a leading
population center focused on research on inequalities in the health and well-being of vulnerable populations,
and on public policies relevant to those populations; and (4) take advantage of Columbia's location in New
York City by partnering with city policy makers and practitioners to address mutual research interests. The
coordinated work of three research infrastructure cores—administrative, computing and methods, and
development—will facilitate cross-disciplinary and cross-campus population dynamics research at Columbia,
with a particular focus on advancing the professional development of junior scientists.
Signature strengths of CPRC are the integration of researchers across three schools (Social Work, Public
Health, and Arts and Sciences); a new emphasis on the cross-cutting themes of inequality and the impact of
public policies on well-being; the diversity of our faculty at both the junior and senior scientist level; the crucial
role of the center in transforming computing infrastructure for population research at the university; and the
substantial leveraging of university support, with an institutional commitment of two times the total requested
NICHD budget. Another signal strength of CPRC are the six vibrant cross-campus working groups, which
complement the work of the PRAs by bringing together scientists from across the campus with shared interests
in autism spectrum disorders, justice and incarceration, the Fragile Families data, policy and population health
dimensions of the opioid epidemic, the environment, climate change, and population health, and housing and
neighborhoods. These vibrant working groups, the PRAs, and the other structures and services provided by
CPRC demonstrate that the center has successfully created and sustained a robust population science research
community that spans disciplinary, geographic, and administrative borders at Columbia.

Public health relevance
Project Narrative – Overall Component The CPRC will contribute to the public's health by facilitating and supporting collaboration for researchers from across Columbia University who, because they are in different departments, schools, or disciplines, would not otherwise be part of a shared intellectual community. Our activities will enhance faculty's research in four areas – children, youth, and families; reproductive health and HIV/AIDS; immigration/migration, and urbanism – with particular emphasis on promoting the development of junior scientists and on the cross- cutting themes of inequality and the impact of public policies on well-being.